Interactive Effects of Prenatal Bisphenol Exposure and Postnatal Maternal Care on DNA Methylation in the Developing Brain

PROJECT SUMMARY / ABSTRACT
Bisphenols (BPs) are commonly used plasticizers that are present in many plastics, such as food storage
containers and reusable water bottles, as well as lining of food cans. BP exposure via oral consumption is
ubiquitous in human populations with inter-individual variation in the levels of exposure. Prenatal exposure to
BPs has been associated with negative neurodevelopmental and behavior outcomes for children in human
epidemiological studies as well as in rodent models of prenatal BP exposure.
BPs such as BPA and other “BPA-free” structural analogs, including BPF and BPS, have been shown to act as
endocrine disruptors that primarily affect estrogen receptor signaling. Previous studies demonstrate that BPs
can bind to both estrogen receptor alpha (ERα) and estrogen receptor beta to exert effects on gene
transcription. Studies using animal models and human placental tissue have demonstrated that BPs can cross
the placenta and exert effects directly on the fetus. Maternal BPs may also disrupt estrogen-dependent
changes in the maternal brain which impairs postnatal maternal care.
Both prenatal BP exposure and altered maternal care are associated with changes in DNA methylation levels
across the genome which can lead to stable changes in transcript abundance of affected genes. However, the
underlying mechanisms linking prenatal BP exposure and DNA methylation modifications at specific loci are
not well-known. In addition, the relative effects of altered postnatal maternal care on offspring with prenatal BP
exposure has been understudied.
The primary objective of my proposed research is to examine the effects of prenatal BP exposure on DNA
methylation modifications at specific loci, notably estrogen responsive elements (EREs), and corresponding
changes in gene transcription in the neonatal rat brain. In addition, I will explore a potentially effective
intervention, maternal licking-like tactile stimulation, to mitigate the effects of prenatal BP on DNA methylation
proximal to EREs in the neonatal rat brain. I hypothesize that DNA methylation changes in response to
increased prenatal BP exposure will be enriched in proximity to EREs in the neonatal rat brain and correspond
to differences in transcript abundance of estrogen-responsive genes. In addition, I hypothesize that postnatal
maternal licking-like stimulation would partially reverse the effects of prenatal BP exposure on DNA
methylation modifications proximal to EREs in the neonatal rat brain via increased ERα binding at EREs.
Training Potential: In tandem with my proposed research project, I will be developing important research
competencies in the developmental origins of health and disease conceptual framework, translational
research, and bioinformatic analyses of multi-omics datasets. Following these training experiences, I aim to be
competitive for an independent research position and successfully transition to research independence.

Public health relevance
PROJECT NARRATIVE Bisphenol exposure in human populations is nearly universal and there is evidence that prenatal exposure to bisphenols is linked to negative neurodevelopment and behavior outcomes in children that continue throughout life. The proposed research will examine the biological mechanisms underlying the long-term effects of prenatal bisphenol exposure, including estrogen receptor signaling and DNA methylation changes, in the developing brain in rat models. Findings from this research project could help propose more targeted and effective interventions for children with prenatal bisphenol exposure to reduce risk of disease and promote healthier outcomes later in life.